Synergistic contributions of cerebrovascular disease and neuroinflammation to Alzheimer's disease in adults with Down syndrome

PROJECT SUMMARY
Down syndrome (DS) is considered a genetic form of Alzheimer’s disease (AD). Most adults with DS have AD
pathology by age 40 and progress to dementia by 60 years old. Studying AD in adults with DS is critical for two
reasons. First, individuals with DS are living longer and most will experience dementia in their lifetimes, so AD
represents an emerging public health crisis in this population. Second, as the pathophysiological progression of
AD in adults with DS is considered similar to AD in the neurotypical population, the study of AD in DS has great
potential to provide insight into pathogenesis, course, and prevention or treatment strategies for the neurotypical
population as well. Despite a primary focus on the precipitating role of beta amyloid in AD, there is increasing
evidence that cerebrovascular disease and neuroinflammation play a critical role in AD pathogenesis and
progression. The proposed study will use a cross-disciplinary approach to understand: 1) the independent and
interactive consequences of cerebrovascular lesions and neuroinflammation on AD pathology and downstream
cognitive decline, 2) the relationship between cerebrovascular disease, blood-brain barrier disruption, and
neuroinflammation with AD pathology, and 3) the postmortem relationships among small vessel cerebrovascular
disease, neuroinflammation, and tau pathology. These aims will be examined in the Alzheimer’s Disease
Biomarker Consortium – Down Syndrome, the largest longitudinal cohort study of aging in adults with DS, by
examining the independent and synergistic impact of cerebrovascular and inflammatory markers on the
pathophysiology and progression of AD in adults with DS.
This fellowship will prepare the applicant, Natalie Edwards, for an independent, translational research career,
centered on the contributions of cerebrovascular disease (CVD), neuroinflammation, blood-brain barrier (BBB)
disruption, and their interactions on the pathophysiology and progression of AD in adults with DS. The
comprehensive training plan focuses on an advanced methodological and biological understanding of the role of
CVD and neuroinflammation in DS-AD through formal coursework, hands-on experience, mentorship, and
professional development. Natalie will be supported by a mentorship team with a long history of collaboration,
commitment to training, and expertise in AD and DS, including Adam Brickman at Columbia University, Elizabeth
Head at University of California, Irvine, and Donna Wilcock at Indiana University. The mentorship team will
provide topical training in AD, DS, neurobiology and neuropsychology of neurodegenerative diseases, vascular
biology, and applied training in neuroimaging, biofluidic biomarkers, and neuropathology and strategies for
career development. The training plan will help Natalie develop an in-depth knowledge in: 1) advanced
neuroimaging techniques, 2) biofluidic biomarkers of AD and neuroinflammation, 3) fundamental
neuropathological techniques and analytic strategies, and 4) developing a novel line of translational research.
.

Public health relevance
PROJECT NARRATIVE This study will examine the independent and interactive contributions of cerebrovascular disease, neuroinflammation, and blood-brain barrier (BBB) disruption to cognitive decline and the progression of Alzheimer’s disease (AD) pathophysiology in adults with Down syndrome (DS). Virtually all adults with DS develop AD and progress to dementia by age 60, but the mechanisms are poorly understood. Through rigorous examination of the relationships of cerebrovascular disease, neuroinflammation, and BBB disruption with AD pathophysiology and cognitive outcomes, using neuroimaging, biofluid, and neuropathological markers, this study has the potential to contribute to our understanding of the pathways underlying AD in adults with DS and the neurotypical population.